Data Analytic Services Core

ABSTRACT - DATA ANALYTIC SERVICES CORE (DASC)
The main goal of the University of Michigan O'Brien Kidney Translational Resource Center (MKTC) is to
provide an effective translational research pipeline to develop novel, mechanistic treatment strategies for patients
with kidney diseases. The continuing need of kidney researchers to mine and extract pertinent knowledge from
multi-scalar data sets has necessitated a new Data Analytic Services Core (DASC). DASC will support the
investigators by assembling large-scale data sets derived from the clinical cohort studies and trials, from model
system studies from the renal research community at large. The key objectives of the DASC will be to empower
investigators to independently mine multi-scale data sets, specifically to:
(a) Understand kidney development and injury in global molecular terms in human disease and models;
(b) Define molecular and clinical markers of diagnosis and progression;
(c) Identify critical pathways for therapeutic attack;
(d) Identify patient populations for focused clinical trials;
(e) Perform longitudinal analysis of multi-scale data linking molecular and phenotypic data;
(f) Identify subjects at risk of disease or disease progression; and
(g) Link specific cohorts with background health systems data to permit risk factor evaluation, prediction
modeling, and outcomes analyses among those not recruited/sampled in specific cohort studies.
The data set(s) hosted by the DASC will span the full translational research pipeline from preclinical kidney
disease model system studies to the human cohort data sets derived. This data will be loaded into DASC-hosted
data mining and sharing platforms which have been developed to enable integration of multi-scale data sets to
be mined, analyzed, and shared by research base investigators. The data mining and analytic interfaces to
interrogate genetic, molecular, histological, or clinical features of interest have been specifically developed
towards the needs of the renal researcher. The DASC will continue this development trajectory while enabling
use by the MKTC research community. The core will provide a suite of independent and complimentary platform
approaches serving distinct needs of the research user personas we have defined in our reginal, national and
global kidney research community.